Regulation of catagen regression and progenitor pruning by the dermal sheath

Project Summary
The hair cycle involves remarkable remodeling of growing hair follicles (HF) in repeated phases of progenitor
death and follicle regression, rest and new hair growth. It is therefore an excellent model for studying regression
and regeneration processes that are executed by epithelial stem cells (SC) and progenitors and regulated by the
niche microenvironment. Signals from the dermal papilla (DP) regulate progenitor proliferation and differentiation
in the bulb of growing HFs, and induce SCs in the hair germ during the rest-to-growth transition to regenerate
fully growing HFs. Recently, signals from the DP were implicated to induce also progenitor death during catagen
regression. During regression, the DP itself needs to relocate from the base of growing bulbs to the SC reservoir
in the upper HF. How this is accomplished has been unknown for decades. We previously identified the dermal
sheath (DS) as a functional smooth muscle that contracts to physically relocate the DP to reach its essential SC-
adjacent position. Here, we will test whether the DS is a potential signaling source that regulates progenitor
death, a process equally essential for propelling catagen regression. We have discovered that the DS
dynamically produces many signaling molecules including transforming growth factor beta (TGF), which was
previously implicated in progenitor death by TGF signals from the DP. With additional preliminary data we
found, however, that the DP is dispensable for pruning progenitor numbers and that the DS is the essential signal
source for regulating follicle regression. In our studies, we will rigorously test the hypothesis that the DS
constitutes a signaling niche that through TGF signaling controls regression in the hair cycle. We will selectively
and inducibly ablate the DS and DP during hair growth and unequivocally determine their requirement for catagen
initiation and progenitor death. We will explore expression of TGFβ pathway components in the DS and TGFβ
signaling in the progenitors, establish a key role of DS-derived TGFβ signaling in progenitor pruning by Tgfβ1
ablations and identify downstream transcriptional targets with combinatorial pSmad2 chromatin
immunoprecipitation and transposase-accessible chromatin sequencing analyses. Finally, we will determine the
molecular components of the TGFβ activation complex at the progenitor-DS interface by smFISH and IF, and
decipher how DS contraction-mediated forces activate TGFβ signaling in whole-follicle contraction assays.
Overall, this work will define key physiological functions of the follicle sheath for regulating progenitor fate, which
may be useful for developing HF regenerative approaches, including manipulating catagen pruning of
progenitors.

Public health relevance
Project Narrative Understanding the molecular controls of hair follicle stem cells and progenitors is essential for developing future hair regenerative therapies. We will explore the signaling mechanisms by which the dermal sheath regulates progenitor cell death during the regression phase of the hair cycle. This work will provide insights into stem cell and progenitor regulation by dermal sheath cells.